Biological Risk Factors for the Prospective Development of Alcohol Use Disorders in Young Adults with Bipolar Disorder and Typically Developing Young Adults

Alcohol use disorders (AUDs) affect up to 60% of individuals with bipolar disorder during their lifetime and is
associated with worse illness outcomes, yet few studies have been performed to clarify the causes of this
comorbidity. Understanding biological risk factors that associate with and predict the development of AUDs in
bipolar disorder could inform interventions and prevention efforts to reduce the rate of this comorbidity and
improve outcomes of both disorders. Identifying predictors of risk requires longitudinal studies in bipolar disorder
aimed at capturing the mechanisms leading to the emergence of AUDs. Previous work in AUDs suggest that
subjective responses to alcohol and stress-related mechanisms may contribute to the development of AUDs. In
bipolar disorder, altered developmental trajectory of critical ventral prefrontal networks that modulate mood and
reward processing may alter responses to alcohol and stressors; consequently, the disruption in typical
neurodevelopment may be an underlying factor for the high rates of comorbidity. No longitudinal data exist
investigating if this developmental hypothesis is correct. To address this gap, we will use a multimodal
neuroimaging approach, modeling structural and functional neural trajectories of corticolimbic networks over
young adulthood, incorporating alcohol administration procedures, clinical phenotyping, and investigating effects
of acute stress exposure and early life stress. Research aims are to identify biological risk factors—i.e., changes
in subjective response to alcohol and associated neural trajectories—that are associated with the development
of alcohol misuse and symptoms of AUDs over a two-year longitudinal period in young adults with bipolar
disorder and typical developing young adults. Longitudinal data will be collected on 160 young adults (50% with
bipolar disorder, 50% female; aged 21-26). This study is a natural extension of the PI's K01 award. How acute
exposure to stress and childhood maltreatment affects subjective response to alcohol and risk for prospective
alcohol misuse and symptoms of AUDs will be investigated. We will test our hypothesis that developmental
differences in bipolar disorder versus typical developing individuals disrupt corticolimbic networks during young
adulthood, increase sensitivity to stress, and lead to changes in subjective response to alcohol and placebo
response increasing risk for developing AUDs. This research project will be conducted by a multidisciplinary
team of investigators with expertise in bipolar disorder, AUDs, substance use disorders, stress, longitudinal
modeling, neuroimaging, and alcohol administration methodology. Essential to successfully improving clinical
prognosis in bipolar disorder are research results that enable better prediction, diagnosis, and treatment based
on the individual. There is a paucity of human clinical research investigating interactions between subjective
response to alcohol/placebo, corticolimbic development during the young adult epoch, and acute exposure to
stress and childhood maltreatment. Findings may inform intervention efforts that are more specific and may serve
as a model for improving life-long outcomes in bipolar disorder and typical developing youth.

Public health relevance
This application describes a research plan for a longitudinal study in bipolar disorder and typical developing young adults aimed at capturing biological risk factors that are predictive of alcohol use disorders. The goals of the research are to investigate longitudinal changes in subjective response to alcohol, placebo response, corticolimbic neural trajectories, stress, and emergence of alcohol misuse and problems during the young adult epoch and interactions with bipolar disorder. Findings may inform prediction models of alcohol use disorders.